Targeted degradation of NaV1.8 as a therapeutic strategy for pain

Project Summary: Targeted degradation of NaV1.8 as a therapeutic strategy for pain.
Chronic pain is a massive global health burden, and therapeutic options for pain are limited and have a spectrum
of adverse effects. Alternative treatments for pain that are specific, effective, and non-addictive are an urgent
need. NaV1.8 channels are critical determinants of nociceptor excitability—they contribute to most of the current
underlying the rising phase of action potentials and have been implicated in human pain conditions and in animal
models of pain. Gain-of-function mutations in NaV1.8 result in painful neuropathies in humans, and a loss-of-
function in NaV1.8 dulls pain sensitivity in animal models. This genetic dichotomy suggests that reducing sodium
influx through NaV1.8 channels can provide analgesia without CNS side-effects or addictive potential. To date,
the principal strategy for targeting these channels has been to directly inhibit sodium conductance through the
channel. While promising, agents with this mechanism of action have not yet been deployed in the clinic. An
innovative approach may be to reduce the number of channels present at the neuronal surface by selective
degradation.
I have generated a bifunctional protein (named UbiquiNaV) composed of a NaV1.8 selective binding sequence
and the catalytic domain of the NEDD4 ubiquitin ligase. This engineered protein should bind specifically to NaV1.8
and subsequently ubiquitinate the channel, targeting it for degradation. My preliminary data shows that
expression of UbiquiNaV in rat DRG neurons reduces NaV1.8 current. This proposal will test the hypothesis that
this bifunctional molecule will reduce nociceptor excitability via selective degradation of NaV1.8 channels. In Aim
1, I will investigate the specificity of UbiquiNaV for NaV1.8 and demonstrate how UbiquiNaV expression impacts
rat nociceptor excitability. Aim 2 will use a live-cell imaging assay developed in our lab coupled with an inducible
activation mechanism to examine the temporal and spatial regulation of NaV1.8 channels in DRG neurons by
UbiquiNaV. Together, my work will a) delineate the mechanism of action of this newly engineered bifunctional
molecule, and b) reveal the selectivity of UbiquiNaV for NaV1.8. In doing so, this work will demonstrate the viability
of targeted degradation of NaV1.8 as an analgesic strategy.

Public health relevance
Project Narrative Chronic pain is the leading cause of disability worldwide and current treatments are ineffective and addictive. UbiquiNaV is an engineered bifunctional protein that enables targeted degradation of an ion channel implicated in human pain conditions – this study aims to evaluate the ability of UbiquiNaV to reduce the excitability of pain- sensing neurons and to reveal the mechanism of this reduction. This study may lead to compounds that enable targeted degradation of peripheral ion channels as novel analgesic agents for non-addictive pain therapy.